Administrative Core

The proposed NTR Center will be led by Lihong Wang, PhD. He will be aided by the Administrative Core, which consists of four project/core leaders and an experienced research business director (Karen Monteiro Kharasch). This diverse group of leaders has been selected to represent a broad range of research interests and leadership expertise. These individuals make it realistic to manage an enterprise of this scope and magnitude. The Administrative Core will be led by Dr. Mintun. Drs. Mintun, Wang, Achilefu, Culver and Ms. Kharasch will review, facilitate and coordinate collaborations among all participants in the proposed NTR Center as well as interactions with other funded Centers within the NTR network. As Division Leaders of the Primary Project (Wang), Task-Specific Projects (Achilefu), Support Cores (Culver &Mintun) and Administrative Core (Mintun), each will facilitate communications back and forth between the Administrative Core members and the other team leaders. As experienced leaders of complex centers, all Administrative Core members realize the importance of clear and consistent communications.